Outreach Core

OUTREACH RECRUITMENT & ENGAGEMENT (ORE) CORE PROJECT SUMMARY/ABSTRACT.
The ORE Core plays an essential role in achieving the proposed goals of the Columbia ADRC by meeting the
outreach, engagement, recruitment, and retention needs of the ADRC, focused especially on our local Northern
Manhattan community. In the previous cycles of the Columbia ADRC, the ORE Core has successfully met
recruitment, outreach, and engagement goals, including the recruitment of ADRC participants from groups that
reflect the different populations of Manhattan overall. In the current application, the Columbia ADRC will focus
on increasing the representation of NIH-designated at-risk population in Alzheimer’s disease and related
dementias (ADRD) research and in clinical trials. Accordingly, our overall goal will be to serve as a liaison
between the local lay community and the ADRC, and to facilitate changes in the research infrastructure towards
best health practices for the broader Columbia ADRD research community. To help meet these goals, and to
continue to meet the outreach, recruitment, and engagement needs of our local Northern Manhattan, larger New
York, and national communities, we propose four initiatives: 1) Develop a registry of adults interested in
research participation that are representative of the surrounding communities. By leveraging the heterogeneity
of the neighborhoods surrounding CUIMC, we will support a registry of older adults in studies of AD/ADRD.
This registry will significantly help increase the generalizability of ongoing research studies at Columbia
and more largely through the ADRC network. 2) Increase community education. Our educational outreach
activities will focus on reducing ADRD stigma, emphasizing brain health and risk mitigation, improving health
literacy related to ADRD biomarkers and clinical trials. 3) Develop a Healthy Brain Aging Community
Advisory Board (CAB). The goal of our CAB will be to support increased engagement, outreach, and education
in the community as it brings groups together to build research from the ground up. In addition, we will advertise
our CAB broadly to ADRD investigators at Columbia to encourage investigators to join a meeting and present
to our Healthy Brain Aging CAB. 4) Influence ADRD research infrastructure towards brain health
practices. Recruitment strategies for at-risk populations have largely emphasized changing the behaviors and
motivation of the individual participant rather than on changes in research design and methods that emphasize
addressing obstacles to research participation. By collaborating with various educational programs and centers
at CUMC such as with Narrative Medicine, and the ADRC Research Education Component (REC), we will
provide various activities to increase the bi-directional relationship between investigators at Columbia with
members of the community to inform best health research practices. We are confident that the Columbia ADRC
ORE Core can continue to meet the evolving needs of the Columbia ADRC and the larger ADRD scientific
community, including the continued involvement, engagement, and recruitment of participants from NIH-designated
at-risk populations.